AGA FORWARD PROGRAM - Fostering Opportunities Resulting in Workforce and Research Diversity

PROJECT ABSTRACT
The pipeline of physician-scientists from underrepresented populations in the biomedical workforce remains
leaky. In gastroenterology, only 4 percent of academic faculty are African American, and 6 percent are
Hispanic/Latinx. American Indian/Alaska Native and Native Hawaiian physicians represent less than 0.2
percent of all academic faculty positions. These numbers are significantly lower than the representation of
these groups within the overall U.S. population. A 2020 survey conducted by the Intersociety Group for
Diversity, a working group of representatives from five digestive disease professional associations including
the American Gastroenterological Association (AGA), illustrated that the primary impediment to success for
physician-scientists from underrepresented populations remains a lack of effective and accessible mentoring.
AGA has a long and successful record of professional development programs designed to improve the
diversity of the research workforce in gastroenterology. AGA has implemented NIDDK-funded programs to
promote the recruitment and retention of underrepresented physician-scientists in gastroenterology since 2001.
Our current program, FORWARD began in 2018 and has demonstrated success in advancing the diversity of
the biomedical workforce with a focus on research skills development, leadership skills development, and
effective mentoring. This competitive renewal application, FORWARD 2.0, proposes to leverage the successes
of the original program with an enhanced focus on 1) manuscript writing and grant-writing training for both
program alumni and current cohorts with tracks specific to NIH K or R01 grant writing, 2) leadership
development and support focused on training and transitioning alumni and current cohort participants to
assume leadership positions within AGA's professional society committee structures and academic medicine
and 3) intensive mentoring from an expanded team of mentors, including senior mentors, home institution
mentors and near-peer mentors, and using mobile app-based mentoring technology.

Public health relevance
PROJECT NARRATIVE The Fostering Opportunities Resulting in Workforce and Research Diversity (FORWARD) Program is a key part of the American Gastroenterological Association's organizational commitment to expand the pool of physicians and scientists from underrepresented backgrounds and reduce disparities in digestive disease. The next phase of the program aims to retain a diverse research workforce in gastroenterology by preparing and aiding the transition of early-career individuals from underrepresented backgrounds to assume leadership positions within the professional association and in academic medicine. We will build on the successes of our initial five years through a comprehensive curriculum covering essential research skills such as manuscript writing and grant writing (with an emphasis on preparation of an NIH K or R01 grant application); leadership skills aimed at preparing and transitioning participants to roles within AGA committees and academic leadership; and intensive mentorship through a team-based approach.